Understanding robust cellular information processing in complex environments and development of enabling single-cell analysis technologies

The overarching goal of our laboratory is to understand how cells process signals and communicate robustly in
complex environments. We combine experiments, modeling, and development of technologies for high-
throughput single-cell analysis. Here, we build upon two grants that proposed fundamental (R01GM128042) and
technological (R01GM127527) studies of immune signaling. Our goals are integrated around two key questions:
How do cells encode information into signaling molecules? Environmental inputs are detected by
sentinel cells, which in response produce cytokines. Recent studies led to the hypothesis that cytokine dynamics
encode information from the environment. Determining how pathogen and stress inputs are encoded is crucial
for understanding infection, autoimmunity, sepsis and cancer. We will use single-cell protein production/secretion
assays and live-cell analysis to answer key questions including: How do cells exposed to multiple sequential
stimuli encode the memory of prior stimuli? How does cellular density and coordination influence cytokine
responses? What are the mechanisms of cytokine production variability by myeloid or epithelial cells, and what
causes excessive cytokine production/secretion? Technologies to analyze single-cell protein
production/secretion: We will realize a method for simultaneous measurement of single-cell expressed
proteins, protein complexes and mRNA using single-cell sequencing readout. High-throughput microfluidic
technologies for time-dependent measurement of proteins secreted by single live-cells will be developed. We
will also develop microfluidic co-culture systems for creating controlled dynamic microenvironments.
How do cells process combinatorial/dynamic signals? Signals generated by sentinel cells are processed
by transcriptional pathways. NF-κB, an inflammatory pathway that controls responses to many signals, is a prime
example of a system that creates fine-tuned responses. We will study NF-κB as a model system to answer key
questions in signal processing in single-cells: How does NF-κB process combinatorial signals? During infection,
immunity and stress, cells are exposed to combinations and temporal sequences of multiple cytokines. How NF-
κB processes such inputs is not understood. How does NF-κB dynamics regulate gene expression in space and
time? While much attention has been given to temporal characteristics of signaling, little is known about how NF-
κB decodes signals propagating over different spatial scales. How do single cells/populations respond to
dynamic (increasing, decreasing, oscillating) inputs? High-throughput live-cell analysis technologies: To
better answer these and other general questions in signaling, we will develop broadly applicable live-cell analysis
technologies: We will develop microfluidic systems that culture, track and analyze single-cells and populations
under predetermined dynamic/combinatorial signals. We will develop microfluidic technologies for spatial
analysis of live cells and cell signaling events. We will develop computational/statistical methods for automated
analysis for image segmentation, cell/organoid tracking, and prediction of cellular outcomes.

Public health relevance
PROJECT NARRATIVE One of the most interesting questions in science is how individual cells robustly communicate with each other in complex and rapidly changing environments using signaling pathways, whose mechanistic details are not understood. Quantitative characterization of signaling pathways in living cells would lead to accurate computational models of emergent signaling outcomes in health and disease, as well as better therapies in a range of conditions including infection, autoimmunity, and cancer. We will use live-cell experiments, modeling and bioengineering approaches to study information processing by individual cells and cell populations, and develop enabling new technologies with improved accuracy and throughput for better study of biological information processing by single cells.